RP3: Targeting ATG gene-dependent immunity for novel anti-infective therapeutics

PROJECT SUMMARY – RP3: The goal of RP3 is to define and pharmacologically target intracellular immune
mechanisms utilizing autophagy (Atg) genes (but not degradative autophagy) to control infection and
inflammation. We discovered these processes in experiments designed to understand the anti-infective
mechanisms of IFNγ, a cytokine essential in both humans and mice for macrophage-mediated resistance to
viruses, bacteria, and parasites. IFNγ is used to treat chronic granulomatous disease and osteopetrosis, but
other uses of IFNγ have been limited by toxicity, a fact generally attributed to IFNγ inducing the expression of a
very large number of pro-inflammatory genes. We theorized that new therapeutics might be generated by
defining the effector mechanisms responsible for the potent effects of IFNγ, and then selectively stimulating
these mechanisms to generate Atg gene-directed broad-spectrum anti-infectives. This led to the discovery that
IFNγ triggers Atg gene-dependent immunity against T. gondii and norovirus (NoV) infection using the same set
of Atg genes (Atg5, Atg7, Atg16L1, Atg12), but not Atg14 or degradative autophagy. The fact that Atg gene-
dependent mechanism(s) controlled two phylogenetically distinct pathogens suggested to us that we might be
able to make compounds that are effective against a broad range of pathogens. During the first CETR funding
period we confirmed this prediction by identifying Atg gene-directed broad-spectrum anti-infective compounds
with activity against norovirus, salmonella, Mycobacterium tuberculosis and Toxoplasma gondii. This discovery
was complemented by discoveries of the role of Atg genes in the regulation of inflammation. RP3 focuses on the
Caliciviridae (most importantly NoVs) which are priority pathogens, causing >90% of the epidemic non-bacterial
gastroenteritis in the world. We discovered murine NoV (MNoV) and cultured NoVs for the first time, providing a
preclinical model in laboratory mice and allowing discovery of Atg gene-dependent immunity. Studies of human
NoV (HNoV) infection had been limited until it was recently found that HNoV grows in cells differentiated from
biopsy-derived human colonic stem cells. This, together with the discovery that MNoV grows robustly in human
cells expressing the proper receptor, and that Atg gene-dependent immunity operates against both T. gondii and
MNoV in human cells strongly argues that these mechanisms are evolutionarily conserved and provide the tools
to identify compounds relevant to a major human disease via the following aims: Aim 1: Develop Atg gene-
directed broad spectrum anti-infective compounds; Aim 2: Define the molecular basis of Atg gene-
dependent IFNγ-induced control of norovirus replication, and identify targets and lead compounds that
trigger this form of intracellular immunity; Aim 3: Define the molecular basis for the regulation of IFNγ
responses by Atg genes and identify lead compounds that up-regulate specific IFNγ effector
mechanisms; Aim 4. Collaborate with other CETR projects to identify autophagy- and Atg gene-directed
broad-spectrum anti-infective compounds.